The role of Zhx2 in CYP2D regulation, oxycodone metabolism, and opioid addiction model behaviors.

PROJECT ABSTRACT
Opioid Use Disorder (OUD) remains a major public health issue, with 2020 containing the highest number
of OUD-related deaths on record. Prescription opioids contribute towards a substantial portion of OUD-related
deaths, with the opioid oxycodone (OXY) among the most prescribed opioids and underlying a significant
percentage of OUDs. OUD-related traits, including use and misuse, behavioral traits, and metabolism have a
heritable component, yet genetic variants underlying OUD traits remain largely undiscovered. Rodent genome-
wide association studies (GWAS) with quantitative trait locus (QTL) mapping can efficiently identify quantitative
trait genes and mechanisms through robustly powered sample-sizes, controlled environmental conditions, and
the ability to perform direct genetic manipulations to validate candidate genes; all distinct advantages over
human system genetics. We previously identified increases in OXY state-dependent reward learning and
locomotion in female BALB/cJ (J) mice compared to the closely-related BALB/cByJ (ByJ) mice, despite these
substrains differing by only ~8,000 genetic variants. These behavioral changes corresponded to increases in the
highly potent OXY metabolite oxymorphone (OMOR) within the brain in female Js. A reduced complexity cross
between Js and ByJs identified a robust QTL on chromosome 15, accounting for 29% of variance underlying
increased whole brain [OMOR] in J females. Further expression QTL analysis using striatal and hippocampal
brain tissue identified the transcriptional repressor gene Zhx2 as our top candidate gene. Js contain a mouse
endogenous retroviral element (MERV) within Zhx2, decreasing transcription and subsequent protein
expression. Zhx2 regulates expression of multiple cytochrome P450 (CYP) enzymes in the liver, the primary site
of drug metabolism, and interestingly we observed increases of brain CYP2D11, a mouse ortholog of human
CYP2D6 that metabolizes OXY to OMOR, correlated to decreased ZHX2 in female Js. Our findings suggest that
decreased ZHX2 expression increases CYP2D expression, consequentially increasing both brain [OMOR] and
OXY addiction model behaviors. The primary objective of this proposal is to assess the contribution of Zhx2 to
OXY addiction model behaviors through regulation of CYP2D expression and subsequent OMOR production in
the brain vs. the liver. In Aim 1, we will identify hepatic transcriptomic and proteomic associations with [OMOR]
and OXY addiction model behaviors through RNA-seq and protein mass-spectrometry. In Aim 2, we will delete
the Zhx2 MERV through CRISPR/Cas9 gene editing to determine the necessity of this genetic variant in
increasing OMOR production and OXY addiction model behaviors. In Aim 3, we will identify the relative role of
brain vs. liver Zhx2 in regulating CYP2D expression, OMOR production, and OXY addiction model behaviors
through tissue-specific AAV genetic manipulations. Our results will provide critical insight into the genetic,
molecular, and tissue-specific mechanisms underlying OXY metabolism and addiction model behaviors that
could have implications for personalized medicine in opioid therapeutics and OUD treatments.

Public health relevance
PROJECT NARRATIVE Opioid Use Disorder (OUD) is a major public health concern in the United States with a record number of opioid-related deaths in 2020 and limited therapeutics for treatment. Discovery-based genetics combined with pharmacological and neurobiological approaches in rodent model organisms are critical for understanding molecular mechanisms underlying susceptibility to OUDs. Our project’s goal in understanding the genetic basis of oxycodone metabolism and addiction model behaviors through a multidisciplinary approach has direct translational relevance to humans and personalized medicine, both in opioid therapeutics and OUD treatments.